Bruker timsTOF fleX MALDI-2

This proposal requests funding for a Bruker timsTOF fleX MALDI-2 mass spectrometer to support
spatial single-cell omics research at Stanford University. The instrument will be placed at the
Stanford Center for Genomics and Personalized Medicine (SCGPM) Genome Sequencing
Service Center (GSSC). Increasing evidence from single-cell studies reveals that spatial
distribution of biomolecules is crucial for understanding tissue complexity,cell to cell
communication and their interaction with microenvironments. Although our facility has a robust
selection of mass spectrometers for bulk omics studies, spatial single cell omics requires
specialized equipment. Currently, our facility excels in supporting spatial single cell
transcriptomics and proteomics, technologies widely available to our researchers. The crucial
missing piece is an instrument capable of studying spatial distribution of small molecules at single
cell resolution. A comprehensive understanding of cellular heterogeneity and the
microenvironment requires not just RNA and protein expression, but also the distribution of small
molecules such as metabolites, lipids and glycans. Correlating small molecule distribution with
gene and protein expression helps establish crucial links between genetic instructions and their
functional consequences. The proposed instrument offers unmatched single-cell resolution for
analyzing the spatial distribution of small molecules, complementing existing spatial
transcriptomics and proteomics studies. This cutting-edge instrument will offer several unique
features: (1) Un-paralleled spatial resolution to single cells for tissue imaging; (2) Fast data
acquisition speed which is essential for imaging large tissue areas and high throughput screening;
(3) Streamlined workflow for easy operation, data visualization and analysis. Access to this
instrument will facilitate multiple levels of translational and basic science research. This includes
constructing molecular maps of human tissues at single-cell resolution, conducting in situ tissue
glycomics analysis for biomarker discovery and disease mechanism investigation in various types
of cancer, and investigating how the alternation of small molecules contributes to lung and
cardiovascular disease, cancer development, aging, and more. Progress on this broad array of
projects will be catalyzed by the effective usage of the new instrument through close cooperation
among the user groups. By serving a highly productive interdisciplinary group of NIH-funded
investigators, the proposed instrument will enhance existing research programs while
encouraging new projects and collaborations to emerge and be funded.

Public health relevance
Project Narrative Successful acquisition of a Bruker timsTOF fleX MALDI-2 mass spectrometer will have a significant impact on spatial single cell Omics studies conducted in multiple departments in Stanford University. The cutting-edge instrument offers unmatched single-cell resolution for analyzing the spatial distribution of small molecules like metabolites, lipids, and glycans, complementing existing spatial transcriptomics and proteomics studies. This instrumentation will support sixteen major and minor user groups to accelerate the pace of ongoing research in many departments at Stanford as well as being available to the broader scientific community.